Incorporating cardiovascular risk assessment into adolescent and young adult visits to improve cardiovascular health

PROJECT SUMMARY
Cardiovascular disease (CVD) is the leading cause of death for American women. While overall mortality from
CVD has declined, event rates among younger women have increased dramatically in recent years.
Cardiovascular health promoting interventions targeted at adolescent and young adult women are urgently
needed to reverse this trend and halt the intergenerational transmission of CVD risk to future generations. The
objective of the proposed research is to increase young women’s perceived susceptibility to CVD and provide
a cue to action to adapt heart healthy behaviors. The aims of the proposed study are to 1) elicit information
about necessary adaptations to an existing lifestyle-based CVD risk assessment tool and companion
behavioral intervention from adolescent and young adult women and their primary health care providers using
qualitative methods; 2) adapt the risk assessment tool and behavioral intervention into a single integrated
mobile application using user-centered design principles; and 3) evaluate the usability and feasibility of
delivering the mobile application with adolescent and young adult women presenting for wellness, mental
health, and reproductive health visits in a pilot clinical trial. We will also examine preliminary outcomes from the
initial trial, including changes in heart healthy behaviors and perceived risk for heart disease, in order to
prepare for a larger clinical trial. Our long-term goal is to shift the paradigm of young women’s health care to
include the prevention of CVD. By integrating this application into usual care, we aim to slow or arrest the
cardiovascular health loss commonly seen as adolescent girls transition to young adulthood, thereby reducing
CVD morbidity for this and future generations.

Public health relevance
PROJECT NARRATIVE The proposed project will provide insight on the usability, feasibility, and preliminary efficacy of an integrated app-based intervention to promote young women’s cardiovascular health during primary and reproductive health visits. Applying feedback from adolescent and young adult women, we will adapt and combine a cardiovascular risk assessment tool and a behavioral intervention tool using innovative user-centered design methods. The proposed research project is relevant to public health because it will address the burden of cardiovascular disease among women by optimizing risk communication and prevention during this critical stage in the life course.